Regulation of H2S signaling in vascular function

Program Director/Principal Investigator (Last, First, Middle): Naik, Jay, S
Impaired endothelial cell (EC) function is one of the first indicators of systemic cardiovascular disease. EC
dysfunction impairs local organ blood flow regulation, a primary cause of end-organ damage in most
cardiovascular diseases. The discovery that ECs also synthesize carbon monoxide (CO) and hydrogen sulfide
(H2S), in addition to nitric oxide (NO), which elicits vasodilation has opened a new chapter in endothelial
gasotransmitter biology. While increasing evidence supports a key role for H2S in cardiovascular homeostasis,
disparate findings in previous studies leaves a significant gap in knowledge on the regulation and significance of
H2S signaling in the vasculature. Recently, we identified a novel regulator of H2S signaling that leads to profound
differences in vasodilatory sensitivity between primary and tertiary segments of the circulation. Intriguingly, our
preliminary data show that H2S dilates small (resistance) arteries in an endothelium-dependent manner at
concentrations that have no effect in large arteries. However, depleting EC membrane cholesterol in large
arteries unmasks H2S-mediated vasodilation, suggesting membrane lipid content and domains regulate H2S
signaling. Moreover, our preliminary data show that native EC cholesterol content is greater in large arteries than
resistance arteries. The concept that innate regional differences in EC membrane cholesterol content mediate
functional differences in EC dilation is wholly novel, and our preliminary data (Fig. 6) demonstrate this may be
caused by increased cholesterol efflux via ATP-binding cassette family a1 (Abca1) and phospholipid transfer
protein (Pltp). Importantly, we have previously shown that changes in EC membrane cholesterol appear to
contribute to dysfunction in disease. Therefore, EC membrane cholesterol is an important but uninvestigated
variable in vascular function. The overall goal of this project is two-fold. First, to elucidate mechanisms leading
to the functionally significant differences we have observed in EC membrane cholesterol content between large
and small arteries. The second is to define ways in vitro and in vivo that these differences in EC membrane
cholesterol control EC function, specifically H2S-induced dilation. Thus, we hypothesize that augmented
cholesterol efflux in EC of resistance arteries enhances downstream H2S signaling
Aim 1: Determine the mechanism(s) leading to heterogeneous membrane cholesterol content between
large and small arteries.
Aim 2: Determine the mechanism(s) by which membrane cholesterol regulates H2S signaling in EC.
Completing the proposed studies will fill an existing knowledge gap by elucidating the regulation of H2S dilation
to identify differences in EC function between small and large arteries. Conceptually, the project is very innovative
in its focus on the novel ability of membrane cholesterol trafficking to act as a regulator of vasodilation. This work
will increase our understanding of the fundamental properties of EC, significantly impacting our understanding
of blood pressure regulation and local blood flow control, and may identify drug targets for the treatment of
multiple vascular-driven diseases.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page

Public health relevance
Hydrogen sulfide (H2S) is an endogenous vasodilator compound produced in endothelial cells that regulates blood pressure and local blood flow. Production and/or activity of H2S is decreased in most cardiovascular diseases. The current understanding of how H2S signaling is mediated is not well understood, limiting therapeutic options to activate or repair the H2S signaling system. This proposal will investigate the functional significance and mechanisms leading to heterogeneous membrane cholesterol content among EC from different sites (Aim 1) and identify role of membrane cholesterol in regulating H2S signaling targets in vascular EC (Aim 2) to understand how this molecule signals in healthy systems, identifying potential targets that may be dysregulated in disease. The project's long-term goal is to identify novel targets for therapeutic intervention in cardiovascular diseases such as hypertension, stroke, and peripheral vascular disease.